BREAST ONCOLOGY PROGRAM

The Breast Oncology Program is comprised of 48 Program Members from 18 different UCSF departments. The Program supports and stimulates basic, clinical, and population research in breast cancer and facilitates the translation of these findings into improved cancer management and control. The Program's themes are as follows: (1) epidemiology; (2) carcinogenesis, early detection and cancer prevention; (3) genetics and biology of cancer progression; (4) identification of new therapeutic targets and approaches; and (5) outreach, clinical care delivery and outcomes. Research awards using funds from the SPORE and philanthropic donors that come to the Program from the Cancer Center stimulate research in these theme areas. Research in the Breast Oncology Program is now supported by the Bay Area Breast Cancer SPORE, a DOD Center of Excellence on "A Blueprint For Regional Excellence In Breast Cancer Care," five large multidisciplinary, multi-institutional projects that support work in one or more themes, and by numerous individual investigator-initiated grants. Interactions between Program Members are encouraged in several discussion forums, including a weekly multidisciplinary seminar, an annual retreat, a weekly tumor board, a monthly community forum, and a patient-physician management discussion series. The Program has $11,393,013 Total peer reviewed support for the last budget year. The Program has 18% intra-programmatic and 41% inter-programmatic publications.